Molecular origins and impact of APOBEC3 mutagenesis in cancer

PROJECT SUMMARY
Mutations arise as a result of exogenous and endogenous processes that leave characteristic imprints or
signatures upon the genome. Systematic analysis of these mutational signatures led to the identification of >50
distinct types of single base substitutions (SBS) in human cancer genomes. Revealing the origins of individual
signatures is critical for understanding cancer etiology, with potential implications for cancer prevention and
therapy. Two of the most prevalent mutational signatures in cancer, termed SBS2 and SBS13, are present in
>78% of cancer types and 56% of all cancer genomes, with a particular prominence in breast, bladder, and
lung cancers. SBS2 and SBS13 are proposed to be caused by the endogenous APOBEC3 (A3) enzymes,
which target ssDNA and RNA of viruses and retroelements as part of the innate immune defense. Correlations
between A3 expression, driver gene mutations in A3-preferred contexts, and clinical outcomes suggest that A3
mutagenesis may play important roles in cancer etiology and evolution. Thus, there is strong rationale to
understand the mechanisms of A3 activity. However, reliance on engineered model systems and correlative
data have caused links between A3 enzymes, mutations in cancer, and cancer etiology to be poorly
understood. We have identified human cancer cell lines with endogenous A3 mutagenesis and developed a
workflow that enables us to quantify contributions of individual A3 members to mutations. Here, we propose to
leverage this workflow to accomplish the following goals: 1) Identify A3 mutator enzymes in cancer types where
A3 mutagenesis is prevalent and find biomarkers of their activity; 2) Investigate mechanisms modulating A3
mutagenesis; 3) Determine the functional relevance of A3 mutagenesis in therapy resistance and metastasis.
Aim 1 will expand upon our characterization of human cancer cells with active A3 mutagenesis to identify A3
mutators in breast, bladder, and lung cancers. In parallel, we will directly assess the unknown specificity and
sensitivity of assays to measure activities of individual A3 enzymes. These experiments may further confirm
the speculative A3-etiology of a large number of cancer mutations and quantify contributions of individual A3
enzymes, thus nominating them as putative targets for therapeutic pursuit. Aim 2 builds on our preliminary data
to investigate proposed modulators of A3 mutagenesis. These experiments have the potential to broaden the
scope of therapeutic opportunities focused on cancer cell evolution. Aim 3 will assess the links between A3
enzymes, therapy resistance and metastasis in breast, bladder, and lung cancer cell lines. These experiments
will test predictions from multi-dimensional associations that A3-mutagenesis is a disease-modifying process
that can be therapeutically exploited at various stages of cancer evolution. Taken together, these studies will
define the etiologies of highly prevalent mutational processes and identify strategies to elicit more durable
clinical benefits to targeted therapies and curb metastasis.

Public health relevance
PROJECT NARRATIVE The endogenous APOBEC3 enzymes are proposed to cause a large number of mutations found in many different cancer types. Using newly discovered human cancer cell line models, we will determine the causes and consequences of APOBEC3 mutagenesis in cancer with the goals of determining if APOBEC3- mutagenesis represents a disease modifying process that can be therapeutically exploited at different stages of cancer evolution and identifying specific enzymes as putative targets for therapeutic pursuit.